Investigating the impact and dynamic of mitochondrial common deletion in somatic cells

Project Summary:
The most common mitochondrial DNA (mtDNA) abnormality is a deletion of 4977 base pairs
called the common deletion (CD), associated with mitochondrial pathologies and widespread in
aging. The CD primarily manifests in the brain and muscles when deleted molecules exceed
60% of total copies, known as heteroplasmy. However, the mechanisms that cause harmful
deletions and why neuronal and muscle cells are particularly vulnerable to CD remain unclear.
Major obstacles to studying the CD is the lack of tools to manipulate mtDNA and the inability to
generate the CD in a controlled manner. Here, we developed a series of methodologies to
overcome these barriers. Specifically, we generated an inducible quasi-dimeric TALEN that
generates the CD in isogenic settings and at defined heteroplasmy states. With this tool, we will
establish low, medium, and high levels of CD heteroplasmy in embryonic stem cells that we will
then differentiate into muscle, neuronal, and fibroblast cells and elucidate the consequence of
this harmful deletion in a cell-type-specific manner and its impact on cellular aging. Furthermore,
we will explore the cell-type-specific distribution of CD, Identifying the pathways that sustain
mutant mtDNA propagation in post-mitotic cells while promoting its elimination in dividing cells.
Combining novel genetic tools with extensive experience in genome stability will resolve the
long-standing mystery of preferential mutant mtDNA propagation in post-mitotic cells and have
significant implications for numerous mitochondrial pathologies and aging.

Public health relevance
Project Narrative Maintaining mitochondrial genomic integrity is necessary to protect against numerous pathologies, including age-related diseases. This proposal aims to highlight the underlying basis for the mitochondrial common deletion, a widespread aberrancy that cripples oxidative phosphorylation and is widespread in aging tissue. By studying the effects and underlying mechanisms of the mitochondrial common deletion, we hope to better understand how mitochondrial dysfunction contributes to age-related diseases.